Development of a targeted TGF-b therapeutic that selectively blocks lung fibrosis in idiopathic pulmonary fibrosis (IPF) patients

Synthis Project Summary/Abstract Phase I NHLBI
IPF is a chronic, irreversible fibrotic lung disease driven by repeated injury, resulting in progressive
stiffening and ultimately, loss of lung function. With 130,000 IPF patients annually and a 5 year mortality rate of
80%, there is significant need for new therapies. To date, conventional therapies have not halted disease
progression. Recently 2 new IPF drugs were approved: pirfenidone, an anti-fibrotic agent and, nintedanib, a
tyrosine kinase inhibitor, but both only modestly delay disease progression. TGF− is one of the key drivers of
fibrosis in IPF patients, due to its elevated and prolonged levels in the lung. On a cellular level, TGF− drives
activated myofibroblasts, the major perpetrators of disease, to over-produce collagen and increase fibronectin
deposition in the extracellular matrix (ECM), which progressively blocks lung function. Inhibition of TGF−-
mediated fibrosis could potentially stop or even reverse disease in IPF patients. However, TGF− is widely
expressed and has essential roles in maintaining tissue homeostasis. Thus, although TGF− inhibitors are of
significant interest to treat fibrosis, development of therapies has been hindered due to significant host (i.e.,
cardiac) toxicity. Safer TGF− inhibitors that selectively block fibrosis in IPF patients, but still protect host
tissues, would provide differentiated treatment options to fill this significant unmet need. In this SBIR award, we
are developing a first in class antibody drug conjugate (ADC) platform to selectively inhibit TGF− driven
fibrosis in IPF patients. In Aim 1, we will develop our novel ADC therapeutic (SYN301) and demonstrate
inhibition of fibrosis in fibroblasts derived from IPF patients, as assessed by a decrease in procollagen
expression and alpha smooth muscle actin in vitro, clinical markers of fibrotic disease. In Aim 2, we will assess
the efficacy of SYN301 in an industry standard, in vivo model of bleomycin induced lung fibrosis. SYN301 will
be assessed for inhibition of disease progression and lung fibrosis as measured by lung histopathology,
inflammatory infiltrates, collagen deposition and BALF immune cell composition. We anticipate that SYN301
will reduce markers of fibrosis both in vitro and in vivo, compared to standard of care therapies. SYN301 is a
first in class therapy that will safely block TGF− induced fibrosis in IPF patients. It is the first ADC molecule
being developed to selectively block TGF− driven fibrosis. Moreover, SYN301 could also be used in
combination with current fibrosis therapies, to increase overall patient response rates. Tissue fibrosis is a wide
spread issue in multiple other diseases, such as NASH, kidney fibrosis and cardiac fibrosis, of which TGF− is
also instrumental in driving disease. Thus, our therapeutic platform is widely applicable to fibrosis in multiple
diseases, providing novel therapeutic options for patients that need it the most.

Public health relevance
Synthis Ph I SBIR NHLBI Project Narrative IPF is an irreversible, fatal fibrotic lung disease with limited therapeutic options that stop disease progression. Synthis is developing a first in class, myofibroblast targeted TGF- therapeutic platform that inhibits IPF disease progression to improve patient response rates.